Administrative Core

Project Summary
The Mount Sinai Center on Health and Environment Across the LifeSpan (HEALS) Administrative Core
provides scientific direction, fiscal management, organizational initiatives, and career development programs.
Our goal is to bring EHS to more and more research programs locally and nationally because environment is
critical to all diseases. Since our Center's founding in 2014, we have built a strong NIEHS funding base with 28
active NIEHS grants- going from the 27th ranked institution in NIEHS funding 10 years ago to #2 today. We
also have 47 other grants from other NIH Institutes and extramural programs working in environmental health
science (EHS). The Center's Career Development Program supports a Center Scientist with funding and
access to career enhancement programs. This program has been particularly successful as four of six past
Center Scientists have received their first R01 and a fifth recently received a 9th-percentile score on her
application. To advance EHS under our life course theme, the Administrative Core supports three Research
Groups—exposomics/ mixtures, environmental justice, and clinical environmental research—that bridge silos
and bring EHS to all of Mount Sinai through seminars, workshops, and journal clubs to discuss cross-cutting
EHS issues. The Administrative Core also oversees 4 Cores: an Integrated Health Sciences Facility Core that
supports biomarker research and population health research, a Biostatistics and Data Science Facility Core
that supports environmental health/toxicology data analysis and generates analytic methods for exposomic
data, and a clinically-oriented Phenotyping and Environmental Modifier Facility Core that supports state-of-the-
art health measures. Our Community Engagement Core implements multi-directional communication and
partnership locally, and its Stakeholder Advisory Board supports the Administrative Core by providing counsel
on policy and environmental issues of local importance. Notably, our community emphasis promoted increased
community-based participatory research (CBPR) Pilot Project funding, with 12 CBPR pilots funded in the last 4
years. Overall, our Pilot Projects Program has been remarkably successful, with 48 of 78 funded pilot grants
awarded to ESIs and a greater than 40:1 return on investment. The Administrative Core receives scientific
guidance from an External Advisory Board of EHS experts and administrative and institutional guidance from
an Internal Advisory Board, composed of senior Mount Sinai Faculty who are directors of other NIH-funded
P30 Centers. Our Center leverages the Mount Sinai Institute for Exposomics Research (see Dean's letter) to
bring additional support to accelerate the Center's scientific breakthroughs in EHS. Our continued expansion is
ensured by the robust infrastructure and leadership within the Administrative Core to leverage institutional
resources and propel the Center forward. In this renewal cycle, we will focus on bringing EHS to additional
research programs through partnerships with our CTSA, other Mount Sinai based P30 Centers and with a new
partnership with City University of New York, the largest Hispanic serving institution in New York.